Administrative Core

SUMMARY
The Administrative Core (Core A) will be directed by Dr. Barbara Burtness, Principal Investigator of the Yale
Head and Neck SPORE in Lung Cancer (YHN-SPORE), and co-directed by Dr. Edward Kaftan with support from
the program financial management team and Michele Dingus, Associate Administrator. Drs. Erica Golemis and
Wendell Yarbrough will serve as Site Leaders for Fox Chase Cancer Center and University of North Carolina,
respectively. Careful oversight by the Administrative Core will be critical to ensure the success of the YHN-
SPORE. The Administrative Core will serve as the central coordination point for all YHN-SPORE investigators,
with responsibility for strategic and scientific direction, and monitoring progress of all projects and cores towards
the translational goals of the SPORE. The Core Director and Co-Directors will have responsibility for leading the
SPORE, setting translational research priorities, identifying new translational research opportunities, monitoring
the progress of all projects, cores and developmental projects and determining changes in direction of projects,
cores and translational research as needed. Interactions among YHN-SPORE investigators will be facilitated by
Core A to accelerate the translation of laboratory findings to the bedside through rational and rigorous
translational and clinical studies. If required, the Core A Director will manage conflicts among SPORE
investigators. As a team, the Core personnel will provide financial oversight, maintain communication among
project and core leaders and coordinate bi-weekly meetings, quarterly meetings of the Executive Committee,
annual meetings of the Internal/External Advisory boards and an annual YSHN-SPORE retreat. In addition to
these functions, the Core will be the primary interface with the NCI, Fox Chase Cancer Center, University of
North Carolina, head and neck or other disease- or pathway-focused SPOREs, Yale Cancer Center and Yale
School of Medicine, and will coordinate outreach efforts, including publications (internal and external), website
development, seminars, and patient/research advocacy activities. Through these administrative activities, Core
A will be essential to the organization of the YHN-SPORE program, to advancing science to overcome treatment
resistance in head and neck cancer, developing models and approaches to advance the field, and mentoring a
new generation of head and neck cancer translational researchers.

Public health relevance
PROJECT NARRATIVE The Administration Core (Core A) is essential for leading the Yale Head and Neck SPORE (YHN-SPORE). The Core will provide scientific, financial and administrative oversight for all YHN-SPORE activities and make critical decisions regarding project oversight and management.